ZIDOVUDINE VS 2,3-DIDEHYDRO-3 DEOXYTHYMIDINE IN HIV+ CHILDREN

The relative safety and tolerance of the new antiretroviral agent, d4T, are compared with that of ZDV in the treatment of symptomatic HIV infection in children.